Automated Multiscale Super-resolution Confocal Microscope

ABSTRACT
The La Jolla Institute for Immunology (LJI) is a premier immunology research institute in the US whose
20 principal investigators are supported by ~$39 million in NIH grants and contracts. At LJI, we study the
behavior of immune cells in diseases prominent in the US and around the world, including viral biology, type 1
diabetes, atherosclerosis, cancer, and inflammation. Nearly all of our scientists use imaging to visualize cellular
interactions, signaling, and function with results published in Nature, Science, and other prominent journals.
However, as our research aims evolve, and to progress further in the research projects listed in this application,
we need a reliable and versatile super-resolution confocal microscope with multiscale imaging capability. The
LJI Microscopy and Histology Core Facility is a dynamic, scientifically driven, multi-user resource with a
remarkable potential for growth. The instrumentation in the LJI Microscopy Core Facility includes an aging Zeiss
LSM 780 that is used by many NIH funded projects, with aims ranging from the investigation of matrix protein
assembly in SARS-CoV-2, novel cell types in atherosclerosis, molecular pathways leading to Type 1 diabetes,
and many others. This system is nearing the end of its useful lifetime and a replacement microscope is needed.
Here, we seek support for purchasing an automated, state-of-the-art, super-resolution microscope that
allows for multiscale, high-throughput investigation of mouse and human tissues. Dynamic biological
processes can be probed thanks to innovative software, highly sensitive detectors, and unparalleled
acquisition speed. After comparing instruments on the market from all major companies, it is clear that the
Zeiss LSM 980 with Airyscan 2 system is the best suited for the needs of LJI investigators and collaborators,
and if funded, it will undoubtedly have a significant impact on NIH-supported scientific progress.

Public health relevance
PROJECT NARRATIVE The LSM 980 with Airyscan 2 confocal microscope requested in this proposal will be a shared resource at the La Jolla Institute that will enable high-throughput, multiscale imaging of samples from the diseases plaguing this country, including viral infection, type 1 diabetes, atherosclerosis, and cancer. Being able to visualize a broad overview and then “zoom in” to study the smallest details of a cell will significantly enhance our understanding of key players indisease initiation, progression, and maintenance of health. This robust, automated system will empower us to view more samples, more quickly, accelerating the pace of science.